Social Media Use and Mental Health among Racially/Ethnically Minoritized Adolescents

PROJECT SUMMARY
Mental health problems among U.S. adolescents have risen precipitously in the past decade, along with social
media use, now a staple of adolescent communication and social interaction. Though many believe this is not
coincidence, evidence linking the two are mixed at best. A deeper understanding of the developmental
connections between social media use and mental health has been severely hindered by a distinct dearth of
longitudinal data, scant examination of the dynamic interplay of social media use and mental health among
racially/ethnically minoritized youth, and a puzzling omission of the mental health implications of social media
content. To fill this critical gap, a longitudinal mixed-methods study is proposed with 250 racially/ethnically
minoritized youth and their primary caregivers. In Phase 1, preliminary data will be collected from 50
adolescents and their primary caregivers to optimize research procedures. In Phase 2, a full-scale longitudinal
data collection will be completed with 200 adolescents and their primary caregivers. Data collection in both
Phases will focus on intensive 9-day-long periods where the research team will (1) use Ecological Momentary
Assessment (EMA) four times per day to measure adolescents’ social media use and mental health in natural
settings and (2) continuously capture screenshots of adolescents’ phone screens every 5 seconds to measure
an individual’s social media content exposure. These “EMA/Screenshots epochs” will be supplemented with (1)
detailed surveys of adolescent social media use, mental health, and other relevant factors from youth-caregiver
dyads and (2) interviews with youth. Phase 1 will only involve 1 EMA/Screenshots epoch and a single follow-up
survey/interview. Phase 2 will involve 9 EMA/Screenshots epochs (3 years x 3 epochs/year in fall, spring, and
summer) and 3 annual surveys/interviews. The Phase 2 design will enable the examination of the bidirectional
dynamics between social media use and mental health on daily (Aim 2) and day-to-year (Aim 3) timescales.
This highly innovative project will provide urgently needed information regarding the development of youth
social media use and mental health across middle to high school ages, their reciprocal influences in both the
daily and yearly timescales, and mechanisms of risk for, and resilience against adverse outcomes. This work
will provide critical insights and information needed to inform interventions aimed at mitigating the negative
impact and maximizing the benefit of social media use for racially/ethnically minoritized adolescents’ mental
health.

Public health relevance
PROJECT NARRATIVE Concern has been raised over parallel increases in social media use and mental health challenges, particularly for racially/ethnically minoritized adolescents, highlighting the need to understand bidirectional associations between social media use and mental health in these youth. This innovative study will use a longitudinal mixed-method design and ecologically valid assessments to provide missing information critical to understanding the bi-directional dynamics between social media use and mental health among racially/ethnically minoritized adolescents. A more comprehensive and accurate understanding of the risks and protective mechanisms will inform the development of targeted, just-in- time interventions designed to reduce the harm and increase the benefit of social media use for vulnerable underrepresented adolescents.